Neuroimaging Core

Project Summary
The overall goal of the Neuroimaging Core (NIC) is to enhance the Cleveland Alzheimer's Disease Research
Center (CADRC) through the application of prospectively acquired advanced imaging and to provide high level
imaging data analysis support and infrastructure to CADRC cores and Alzheimer's disease and related
dementia (AD/ADRD) researchers both regionally, nationally, and through the National Alzheimer's
Coordinating Center (NACC). Specifically, the NIC will prospectively acquire high quality MRI and PET data in
CADRC participants, as well as better than 0.2mm isotropic spatial resolution ultra-high field MRI in ex-vivo
brains of donors to the CADRC. The NIC will provide neuroimaging expertise to investigators in the CADRC
and the general AD/ADRD. There are five aims of the NIC, 1) In addition to acquiring ADNI-compatible MRI
data, to collect high quality multi-modal MRI data that will permit studies of quantitative T1, T2, cerebral blood
flow, tissue microstructure, and blood brain barrier integrity, 2) to establish methods to permit acquisition of
harmonized amyloid PET images across multiple centers using latest generation scanners and techniques, 3)
acquire ultrahigh spatial resolution 7 tesla MRI images in ex-vivo brains of donors, and provide for comparison
to subsequent histopathology, 4) perform detailed quality assurance and curation of data for dissemination to
the NACC and broadly to the AD/ADRD research community, and 5) to train and mentor new and early career
investigators in advanced imaging analysis techniques. The NIC builds on the strengths of the imaging
environment in Northeast Ohio to enhance the imaging resources and data available to the AD/ADRD research
community.